Cancer Modeling Shared Resource

PROJECT SUMMARY: CANCER MODELING SHARED RESOURCE
The Sylvester Comprehensive Cancer Center (Sylvester) Cancer Modeling Shared Resource (CMSR) has
developed into an essential translational research resource for Sylvester members. The aims of the CMSR are
to 1) develop novel mouse models of human cancer; 2) validate cancer targets and test potential therapeutic
approaches using those models; 3) characterize cancer models and evaluate treatment responses using
noninvasive imaging; 4) provide histopathological analysis; and 5) offer training and consultation. In 2017,
Daniel Bilbao, PhD, MBA, was recruited to Sylvester to develop the infrastructure needed to support preclinical
and translational studies, using the mouse as a model organism. One and a half years later, the CMSR was
established as a developing Shared Resource (SR). Driven by the success of the CMSR in achieving metrics
comparable to other CCSG-supported Sylvester SRs (in terms of usage, scope of services, and publications
and grants supported), the CMSR is now proposed as a full CCSG-supported SR. CMSR services facilitate the
in vivo modeling of human cancers, including Sylvester priority cancers, such as hematological and
gastrointestinal malignancies and hormone-related cancers, providing high-quality preclinical data for
successful drug development or evaluation of novel treatment protocols. CMSR’s growth and success are
driven by the Center-wide interest in translational research, significant Sylvester investment in imaging and
other sophisticated instrumentation, and continued expansion in the services provided by the talented CMSR
team. Over the current reporting period (6/1/2018-5/31/2023), to meet the needs of Sylvester members, the
CMSR expanded its services by acquiring 21 instruments, including six new state-of-the-art imaging and
histology platforms (e.g., 9.4T MRI, PET/CT, and automated IHC) and providing numerous new services. This
led to a more than doubling in the number of members using the facility annually, from 28 members in FY19 to
63 in FY23 (Sylvester’s fiscal year (FY) runs 6/1-5/31). To support this growth in services, CMSR staff
increased from three to 13 personnel, and the facility’s space expanded 2.8-fold, to 3,662 sq ft. Over the
reporting period, the CMSR provided services to 83 Sylvester members from all four Research Programs, who
comprised 87% of total usage by revenue, reflecting CMSR services’ critical importance to members. CMSR
supported 37 cancer-related publications, including 19 in high-impact journals (JIF≥10), and 35 cancer-related
grants awarded to members, including 11 from the NCI. Future plans include expanding mouse modeling with
gene editing services; enhancing histopathology services related to digital pathology; expanding noninvasive
imaging protocols for tumor detection and therapeutic responses; and expanding coordinated multi-SR support
for translational research.